Leveraging Data Science and Informatics in an Automated Detection System of Surgical Errors

Technological advancements continue to improve surgical outcomes. However, these
technologies also introduce new challenges such as communication complexities, equipment
troubleshooting under intense pressure, and higher cognitive demand on OR team members. In
other words, surgery will continue to be risky despite technological improvements. There is
evidence the number of avoidable complications may be underreported, that approximately 39%
of in-hospital adverse events are surgical related, and that as many as 4,000 surgical never
events (events which should not have occurred) happen in the US each year.
The eventual goal of this research is to develop an automated detection system (ADS) of high-
risk surgical states. The ADS will prevent surgical safety incidents before they occur through
real-time monitoring and notification of appropriate operating room (OR) team members ahead-
of-time if there is a looming risk. Thereby allowing the team to reconsider next steps and
address the underlying issues, and hence reduce the rates of negative surgical outcomes.
This project demonstrates the feasibility and merit of essential components for an ADS.
Specifically, the surgical safety literature provides compelling evidence that surgical work-flow
disruption (FD) sequences are informative indicators of error causation, therefore it is likely that
a future ADS will model and monitor surgical state through tracking flow disruptions. Our current
aims are to (1) finish implementation of the Research & Exploratory Analysis Driven Time-data
Visualization (READ-TV) research tool; open-source software to visualize FD patterns and other
longitudinal data. (2) Develop a stochastic model to predict whether high-risk, disruptive FD
sequences will occur based on FD rates at earlier time points. (3) Link FD patterns and
sequences with surgical outcomes by developing a text classifier to identify whether or not a
surgical safety incident or near-miss occurred based on the associated EHR note. The classifier
will be a deep learning model trained with tens of thousands of surgical EHR notes.
The text analysis in the third aim will provide insight to FD types and sequences that are more
error prone, thereby revealing the FD patterns that an ADS should warn an OR team to avoid.
Additional benefits of this text analysis include a possible confirmation of the existence of
incident underreporting.
Upon completion of the 3 aims, we will have a computational foundation for an ADS: our
research tool (aim 1: READ-TV visualization software) and analyses (aim 3: link flow disruptions
to safety incidents through EHR note analysis) will advance interpretation of flow disruption (FD)
sequences, and our stochastic models (aim 2: predict future surgical state from FD sequences)
will prospectively predict error-prone states. This foundation can be extended in future projects
through research in automatic transcription of flow disruptions, and the proper mode of alert
delivery if the surgery is prone to enter an error-prone state.

Public health relevance
Surgery by nature is risky for the patient and will continue to be so for the foreseeable future despite technological advancements. The surgical safety literature provides compelling evidence that surgical work-flow disruption (FD) sequences are informative indicators of error causation, and we propose that an automated detection system (ADS) can detect if a surgery has an entered a high-risk state through monitoring of FD sequences, thereby alerting the OR team and preemptively preventing a safety incident. As the first steps for such a system: our research visualization tool (Aim 1) will advance interpretation and clustering of FD sequences, our text-based artificial intelligence models (Aim 3) will link FD patterns and surgery characteristics to safety incidents through computational analysis of over 150,000 surgical notes, and our stochastic models (Aim 2) will verify that a high-risk surgical state can be predicted ahead-of-time by monitoring disruption sequences.